Unifying Mechanism of Oxidative Stress and Inflammation in AMD

PROJECT SUMMARY
Age-related macular degeneration (AMD) is a leading cause of vision loss, yet the molecular events that initiate
the early retinal defects that lead to visual dysfunction remain poorly understood. The objective here is to
examine a role for the stress response protein regulated in development and DNA damage 1 (REDD1) in the
impaired adaptive response of retinal pigment epithelium (RPE) with aging and consequently development of
AMD. Proof-of-concept studies support a potential role for REDD1 in AMD pathophysiology. In fact, intravitreal
administration of a siRNA targeting the REDD1 mRNA has demonstrated promise for improving visual function
in patients with AMD. However, we recently discovered that the REDD1 protein acts as a molecular redox sensor.
Specifically, a reversible redox-sensitive disulfide bond prevents degradation of REDD1 by lysosomal
proteolysis. Consequently, retinal REDD1 inhibition by siRNA-mediated knockdown may only be partially
effective for reducing REDD1 protein expression in retinal disease. The central hypothesis is that activation of
the REDD1 redox-sensor in RPE promotes oxidative stress, inflammation, and retinal pathology in AMD. To test
the hypothesis, we will employ a preclinical murine model of non-neovascular AMD, transgenic REDD1 mouse
lines, and human iPSC-derived RPE in three specific aims. Aim 1 will examine a role for REDD1 as a dominant
governor of the nuclear factor erythroid-2-related factor 2 (Nrf2) antioxidant response in RPE. We predict that
REDD1 prevents a proper antioxidant response in AMD by promoting Nrf2 nuclear exclusion. Aim 2 will
investigate a role for REDD1 in RPE inflammation and trans-differentiation via activation of the transcription
factor nuclear factor kappa B (NF-κB). The proposed studies will explore NF-κB signaling in AMD models and
evaluate the expression of NF-κB target genes, including pro-inflammatory cytokines and epithelial-to-
mesenchymal (EMT) transcription factors. Aim 3 will utilize REDD1 knockout mice and a newly developed
REDD1 point mutation knockin mouse that expresses a REDD1 variant that is continuously degraded by
lysosomal proteolysis to evaluate the formation of hyper-reflective foci, RPE damage, photoreceptor thinning,
and impaired visual function in non-neovascular AMD. It is well established that oxidative stress and inflammation
are crucial factors in the development and progression of the complications that cause visual impairment. The
studies herein are significant because they are designed to identify and characterize specific molecular events
that contribute to oxidative stress and inflammation in AMD by addressing key knowledge gaps related to a
cutting-edge therapeutic target. To do so, we will explore the concept that activation of the REDD1 redox sensor
is a unifying molecular mechanism for improper activation of Nrf2 and NF-κB in AMD.

Public health relevance
PROJECT NARRATIVE An deficit in understanding of the molecular events that contribute to the development of age-related macular degeneration represents an obstacle to the design and implementation of therapeutics that more fully address its molecular pathogenesis. The present application will identify a novel mechanism that contributes to the failed antioxidant and inflammatory responses in retinal pigment epithelium with aging. These findings are expected to provide new targets for intervention and lead to the development of innovative therapies that target a leading cause of blindness.